Novel antigen tests for diagnosing active T. pallidum infection

Abstract
Syphilis is a sexually transmitted infection caused by bacterial pathogen Treponema pallidum (T. pallidum). Alt-
hough it can be effectively treated with a single dose of long-acting penicillin, syphilis is re-emerging as a global
public health problem. According to the CDC, the cases of adult and congenital syphilis in the U.S. increased
74% and 203% from 2017 to 2021, respectively. Therefore, there is an urgent need for better preventive
measures for syphilis. Currently, most syphilis cases are diagnosed based on serum antibody tests that have
been used in some fashion since the 1930s. In addition to imperfect specificity and sensitivity, serum antibody
tests are unable to reliably distinguish between current and past infections, leading to under diagnosis and over
treatment. The overall objective of this project is to develop a one-step, rapid, and low-cost point-of-care (POC)
diagnostic assay for active T. pallidum infection. This POC assay is predicated on the recently developed
Nano2RED technology, an in-solution assay pipeline that transduces antigen binding signals into physical ag-
gregation of binder-functionalized gold nanoparticles (AuNPs) in < 30 minutes with atto- to pico-molar sensitivity.
In this study, we will first engineer specific T. pallidum antigen binders templated on designed ankyrin repeat
protein (DARPin), a versatile low-cost antibody-mimic protein scaffold with high tolerance to harsh/denaturing
conditions and long storage stability (Aim 1). Next, we will create DARPin-based Nano2RED (DARPin-RED)
and determine its sensitivity and specificity against a panel of syphilis patient samples (Aim 2). Since DARPins
can be easily engineered to bind diverse targets, the successful completion of this project should yield not only
a novel syphilis diagnostic assay for active T. pallidum bacteremia, but also a plug-and-play assay platform for
potentially many other infections and diseases.

Public health relevance
Narrative The CDC reported over 176,000 cases of syphilis in the U.S. in 2021, which is a 74% increase from 2017. The current serum antibody-based diagnostic tests for Syphilis are unable to distinguish current and past infection and suffer from imperfect specificity and sensitivity. This project aims to develop a rapid (< 30 minutes) and low- cost (<$3 per test) point-of-care diagnostic assay for active Syphilis.